Alcohol-Involved Sexual Assault Risk the Routines of Daily Life: A Social Goal Perspective

ABSTRACT
Sexual assault (SA) is a significant problem affecting young adult women. The routine social
activities in which women engage are a critical mechanism of assault risk, one that is not well
understood. As such, directions for prevention are few. In the proposed study, we will examine
the ways in which women may enter into and navigate high risk contexts and activities (routine
risk activities) that are known to be associated with SA. This examination will focus on social-
interpersonal goals, which we believe to be at the core of SA risk. We also will examine capacity
for self-regulation, and peer influences, which may augment or buffer against this risk. Our
sample will be a longitudinal community sample of young women initially recruited at ages 11-12
(R01 DA020171; Colder, PI; Read, Co-I) and now in a peak period of victimization risk. We will
used a mixed method design to examine these processes as they occur dynamically in young
adult women (Aim 1; weekly burst design) and we will take advantage of the historical data that
we have from this sample to also test developmental processes that may lead to risk (Aim 2;
longitudinal panel design). Finally, we will link dynamic, shorter-term changes in interpersonal
processes to longer-term developmental processes (Aim 3).

Public health relevance
PROJECT NARRATIVE The objective of the proposed study is to delineate socio-developmental and interpersonal pathways that lead to vulnerability for alcohol-involved sexual assault (ASA). In a longitudinal community sample, we will use a measurement burst design to examine individual and environmental risk for ASA, and whether this risk can be predicted by early social development.